Core 1: Metabolomics

PROJECT SUMMARY – CORE 1
The liver is of central importance to whole-body metabolism, with major roles, among others, in glucose and fatty
acid metabolism, and cholesterol and bile acid synthesis. Excess nutrition leads to the development of aberrant
fat deposition, which contributes to metabolic stress and the potential for progression of liver disease to
hepatocellular carcinoma (HCC). Study of metabolism is therefore of great relevance for understanding the
development of HCC and is a central theme within this P01 application. Core 1 will support the metabolic
research in Projects within this program both by providing an analytical service and by provision of expert advice
on the design of experiments and interpretation of results. Core 1 will quantify metabolites and measure the
stable isotope content (labeling) of metabolites in cells and tissues, and will use the labeling data to calculate
metabolic flux. Areas of metabolism of specific interest are glycolysis, the pentose phosphate pathway, TCA
cycle, fatty acid synthesis, cholesterol, oxy-sterol, bile acid and hexosamine metabolism. These assays will be
implemented for in vitro cell and tissue slice cultures, and in vivo, with analysis of liver, tumor, and plasma
specimens. Through these studies, we aim to contribute to knowledge of the metabolic landscape of HCC, and
how by differing from normal metabolism it might offer avenues for therapeutic intervention leading to improved
HCC treatment.

Public health relevance
NARRATIVE – CORE 1 Fatty liver disease is a frequent precursor to hepatocellular carcinoma. The primary hypothesis of this Program Project Grant is that stress-altered metabolism in the fatty liver leads to further dysfunction in metabolism which contributes to disease progression. The Metabolomics Core will use methods of metabolite quantification and stable-isotope tracing to support Research Projects in an extensive analysis of liver and tumor metabolism.